Longitudinal Adherence to Colorectal Cancer Screening in the VA

PROJECT SUMMARY AND ABSTRACT
Colorectal cancer (CRC) is the second leading cause of cancer death in the US. Despite overwhelming
evidence that screening reduces both CRC incidence and mortality, less than two-thirds of eligible adults are
up-to-date with screening. These figures also overestimate the proportion of Americans who receive adequate
long-term protection from CRC because they are based on one-time, cross-sectional measurements. To
ensure that eligible populations receive maximal benefit from CRC screening, it is critical to accurately
measure adherence to different screening strategies over multiple cycles, to identify the various barriers to
repeated screening, and to translate this information into effective interventions that can be implemented
rapidly and efficiently. This K08 proposal will address the following three specific aims: (1) Quantify longitudinal
adherence to screening colonoscopy and FOBT/FIT in the national VA database over a 15-year period; (2)
Identify social and contextual barriers and facilitators to longitudinal adherence using a qualitative approach in
veterans who are due for repeat screening/surveillance colonoscopy at an urban VA hospital; and (3) Assess
the feasibility of a pilot bidirectional text messaging intervention on attendance for screening/surveillance
colonoscopy and bowel preparation quality. This will be the first study to compare longitudinal adherence to
screening colonoscopy and FOBT/FIT and one of the first to investigate the influence of text messaging on
colonoscopy adherence. This award will allow the PI to obtain additional training in quantitative and qualitative
methods, behavioral intervention design, and mHealth. Findings from the proposal will provide important
insight into the optimal long-term CRC screening strategy and methods to improve adherence to repeat
screening. This will form the foundation of a subsequent R01 grant and help the PI develop into an
independent investigator.

Public health relevance
PROJECT NARRATIVE Colonoscopy and fecal occult blood testing (FOBT) are two screening tests that have been shown to reduce deaths from colorectal cancer, but it is not known what proportion of the population receives consistent repeat screening over many years. This study will measure adherence to long-term screening, identify reasons why individuals do not undergo repeat colonoscopy, and test text messaging as a tool to encourage attendance at colonoscopy. The overall goal of this study is to improve colorectal cancer screening and reduce colorectal cancer death at the population level.